Visual perception in schizophrenia: assessing predictive processing in the earliest stages of the visual cortical hierarchy

PROJECT SUMMARY
Schizophrenia is a serious psychiatric disorder characterized by hallucinations, delusions, and disordered
thinking and behavior that impairs daily functioning. As per the NIH’s Research Domain Criteria framework, we
might gain a deeper understanding of this disorder by focusing on basic dimensions of functioning and how they
relate to behavior and neural systems. With this in mind, research in recent years has sought to link psychosis
with dysfunction in “predictive perception”. According to this framework, perception is an intrinsically predictive
process that involves inferring the causes of our sensory inputs by combining those inputs with prior beliefs about
the states of the world. And it has been proposed that psychosis is the result of maladaptive inferences based
on inappropriately weighting prior beliefs relative to sensory input. However, testing this idea is complicated by
the challenge involved in interpreting neurophysiological measures of perception in terms of feedforward sensory
activity vs top-down predictions, and by the heterogeneity seen across individuals with schizophrenia. With these
issues in mind, we propose to use innovative stimuli to derive EEG responses from the earliest stages of human
visual cortex that are not overly complex in terms of their hierarchical generative architecture, and to relate those
responses to measures of psychosis across healthy individuals, patients with schizophrenia, and patients with
bipolar disorder. Specifically, we will collect high-density EEG from two innovative experiments. The first
experiment aims to derive so-called “perceptual echoes” from human visual cortex. These “echoes” are novel
measures of recurrent activity in early visual cortex that have been modeled as outputs from a predictive coding
architecture. The second aims to leverage a powerful visual illusion to dissociate weak bottom-up stimulus
changes from strong top-down predictions. Using the data from these experiments, we will compute impulse
response functions that characterize early visual processing. To isolate an index of top-down feedback for each
experiment, we will use comparative analyses (comparing impulse response function characteristics across
latencies for Aim 1 and across experimental conditions for Aim 2). We will supplement our understanding of
these indices – and produce additional dependent measures – by modeling the causal connectivity architecture
underlying our impulse response functions. Finally, we will use linear mixed effects modeling to test the
hypothesis that top-down predictive processing (as indexed by both impulse response functions and connectivity)
relates to positive symptoms of psychosis transdiagnostically. Overall, the project aims to produce robust and
interpretable indices of top-down predictive perception that will deepen our understanding of the symptomatology
and underlying pathophysiology of psychotic disorders, which in turn, could improve early detection or provide
biologically inspired alternatives to the current DSM nosology.

Public health relevance
PROJECT NARRATIVE Further progress on improving outcomes for people with psychosis would benefit greatly from a deeper understanding of the neurophysiological mechanisms underlying their symptoms and objective biological markers of disease. One promising route toward these goals is through considering the idea that perception is a predictive process and that psychosis might arise as a result of maladaptive inferences based on inappropriately weighting predictions (prior beliefs) about the environment relative to one’s sensory input. Through this lens, we propose to use novel stimuli to derive electroencephalography (EEG) responses from the earliest stages of human visual cortex, use computational modeling of those responses to derive quantitative indices reflecting top-down predictive feedback, and test how those indices map to positive (and other) symptoms of psychosis transdiagnostically (using well-matched healthy controls, patients with schizophrenia and patients with bipolar disorder).